SR Gene Therapy

The staff within the Gene Transfer, Targeting and Therapeutics Core (GTS) provide expert consultation for the safe and effective use of viral vector technologies, and offer custom design and production services for multiple viral vector types. The GTS facilitates the use of these powerful research tools by Salk researchers and others across diverse fields of study such as systems neuroscience, stem cell biology, metabolism, ageing, cancer biology and gene therapy. All CCSG supported core are organized into one group: Basic Research. This shared resource is categorized as (1.03) Molecular Biology in summary ID

Public health relevance
RELEVANCE (See instructions): Gene therapy, through the use of modified viruses, is an important tool for modern cancer research. This resource will provide support for the design and development of novel viruses and their production for use by Cancer Center investigators.